PROTECT-Wazee: Improving care for older adult trauma patients in Tanzania: guideline adaptation for low -resource setting

ABSTRACT
Trauma kills nearly 4.4 million people every year globally with 95% of deaths in low-and-middle income
countries (LMICs).The World Health Organization predicts 80% of older people (>60 years) will be living
in LMIC by 2050. Like many LMIC, older adults have more than double the mortality rate, longer hospital
stays and worse functional outcomes compared to all trauma patients after acute injuries at Kilimanjaro
Christian Medical Center. While high income settings have created clinical practice guidelines to
standardize and improve care, resources in these guidelines are unavailable and their implementation
is challenged by cultural practice. This proposal will adapt a high resource setting clinical practice
guideline for managing older adult trauma patients to make it more appropriate and feasible for a lower
resourced setting. This project will benefit Tanzanias with a guideline to standardize and improve care,
but also all older adult patients of lower resource settings as we create a flexible clinical practice
guideline generalizable to a myriad of settings.

Public health relevance
Project Narrative Trauma kills nearly 4.4 million people every year globally with 95% of deaths in low-and-middle income countries. Older adults have worse outcomes compared to all trauma patients after acute injuries. This proposal will adapt a high resource setting clinical practice guideline for managing older adult trauma patients to make the guideline appropriate and feasible for a lower resourced setting.